Elucidating functional mechanisms for drug resistance in HIV-1 protease

? DESCRIPTION (provided by applicant): This proposal addresses the problem of drug resistance in HIV-1 protease, an enzyme essential to the maturation of HIV infection to Acquired Immunodeficiency Syndrome (AIDS). Unique HIV-1 protease constructs with mutations known to cause drug resistance will be studied using a combination of Electron Paramagnetic Resonance (EPR), Nuclear Magnetic Resonance (NMR), and a host of biochemical and molecular biological analysis techniques. The constructs will be characterized in terms of structural properties, functional properties, enzymatic activity, and drug resistance. The expected outcome is to determine a relationship between enzyme structure, function, activity, and drug resistance that can be used to understand the problem of drug resistance from a functional perspective and aid in devising new strategies for treatment of HIV infection on a global scale. Another major goal of this funding opportunity is to provide a diverse training environment for the funded individual to aid in preparation for a career as a significantly productive independent researcher.

Public health relevance
PUBLIC HEALTH RELEVANCE: The objective of this proposal is to provide the science community with a new understanding of the causes of drug resistance in increasingly prevalent forms of HIV 1 protease, an enzyme essential to maturation of HIV infection to Acquired Immunodeficiency Syndrome (AIDS). The project involves a unique combination of analysis techniques aimed at elucidating the correlation between structural properties, functional properties, and behavior of the enzyme. Achieving the goals set by this proposal would constitute a pivotal step in understanding, on a global scale, the true mechanisms for drug resistance in HIV infection.